Harnessing the power of digital caging and artificial intelligence (AI) to improve animal welfare and husbandry operations at Rutgers University-New Brunswick

Abstract: Rutgers the State University of New Jersey, New Brunswick campus requests funds to purchase and
outfit fourteen Individually ventilated racks (IVC) in the facility with Digital Ventilated Cage (DVC) retrofit kits and
Rack Environmental Monitoring (REM) system supplied by Tecniplast. The animal facility currently serves the
needs of federally funded multidisciplinary faculty associated with the various schools within the university. The
project will enable the conversion of the existing mouse caging system to an advanced caging system that uses
machine learning (ML) and artificial intelligence (AI) to monitor the animals 24 x7. This advanced caging system
will provide us with multiple cage and room monitoring capabilities, all of which are not currently available in the
facility. The integrated DVC system includes sophisticated sensors along with a software analytics interface that
is easy to use for the animal care takers in the room as well as management personnel for decision making. The
individual sensor boards for each cage will detect the microenvironment within the cage (activity of animals,
presence of food, water, bedding condition) while the rack level REM device will monitor the macroenvironment
(temperature, humidity, lighting, noise, vibration, and human presence). Information captured from these
systems will help 1) streamline operations through the ability to identify each cage and track census at all times,
2) improve animal welfare through detection of sick animals early leading to timely veterinary intervention, 3)
identification of wet bedding or floods in a cage, 4) identify low food or lack of water bottle in cage, 5) timing of
humane end-points to assist with both welfare and tissue/sample collection, 6) identify variables that can affect
research reproducibility and help management correct the variable in a timely manner and 7) improve operational
efficiency. Digital capture of information and the ability to view the information remotely will help streamline
workflows and enable staff to spend less time on administrative tasks and devote more time to animal care.

Public health relevance
Project Narrative: Rutgers University-New Brunswick is requesting funds to convert fourteen IVC racks to a smart artificial intelligence (AI) enabled system to monitor the animals and fourteen environmental monitoring (REM) devices to monitor the macroenvironment of the animal housing rooms. This novel digital ventilated caging (DVC) will enable continuous (24 x7) monitoring of animals in their home cage, help detect early clinical signs of disease or discomfort in animals, prevent human errors such as missed low food or lack of water bottles in the cages, identify soiled bedding using a digital biomarker-bedding status index, increase operational efficiency, and improve animal welfare. The REM devices will help facility management monitor extrinsic variables for research such as noise, light, temperature, humidity, vibration and correct the variables in a timely manner to improve reproducibility of research results.